TAS::75 0872::TAS REDSII (0-8470217)

The objectives of the Retrovirus Epidemiology Donor Study-II (REDS-II) are to conduct epidemiological, laboratory, and survey research on volunteer blood donors to ensure the safety and availability of the blood supply. This includes monitoring known blood-borne infectious agents, rapidly evaluating the impact of emerging pathogens, assessing the safety implications of changes in laboratory and/or blood donor screening protocols and examining blood supply and availability issues. Addressing issues concerned with the safety and availability of the blood supply serves as the cornerstone of REDS-II. The study consists os a coordinating center, six blood centers and a central laboratory.